Epigenetic and Genetic Vulnerabilities in Synovial Sarcoma

ABSTRACT
RP-4 focuses on synovial sarcoma, an aggressive pediatric/young adult sarcoma driven by the SS18-SSX
fusion oncogene. SS18-SSX has emerged as a multi-faceted disruptor of epigenetic control that mediates
genome-wide transcriptional deregulation, resulting in proliferation and aberrant or arrested
differentiation. Our overall goal is to probe the basic pathobiology of synovial sarcoma so as to nominate
potential therapeutic targets. We propose hypothesis-driven screening approaches, namely functional
genomic screens to uncover vulnerabilities among chromatin/transcriptional regulators and among
kinases, as well as targeting the oncogenic fusion itself. Based on the hypothesis that SS18-SSX causes
synovial sarcoma cells to possess special “epigenetic” dependencies, we will, in Aim 1, (a) perform a broad
functional genomic screen using a new CRISPR knock-out pooled library against epigenetic modulators;
and (b) seek to further validate and understand mechanistically KDM2B, a dependency identified in
preliminary studies, as a vulnerability in human synovial sarcoma cells. Based on the hypothesis that
another effect of SS18-SSX is transcriptional deregulation of growth signaling, Aim 2 will employ three
orthogonal strategies to better define targetable kinase vulnerabilities in this sarcoma. Specifically, we will
(a) perform a CRISPR-based functional genomic screen against kinases in human synovial sarcoma cell
lines; (b) identify activated kinases in synovial sarcoma by phospho-protein profiling of patient-derived
xenografts; and (c) define the targets of pazopanib in synovial sarcoma by two complementary methods,
affinity proteomics and PLATO (parallel analysis of translated ORFs). These two analyses should clarify the
critical kinase targets of this multi-targeted kinase inhibitor that is active in a subset of synovial sarcoma
patients. The results generated in this Aim will be integrated to form the basis for more rational targeting of
critical kinases in this sarcoma. As SS18-SSX is the primary driver oncogene in synovial sarcoma, the
junction point of the fusion transcript represents an rational and highly specific target for sequence-based
therapeutics using new antisense oligonucleotide (ASO) approaches. Building on our promising results
using gapmer ASOs to directly target other sarcoma fusions in vitro and in vivo, we will optimize and
evaluate gapmer ASOs against SS18-SSX. In Aim 4, we will validate the targets identified in Aims 1-3 by
confirming on-target effects and expression in human tumors, and we will perform preclinical evaluation of
their potential as therapeutic targets in vitro and in vivo. The most promising targets will be validated and
subjected to extensive preclinical evaluation using multiple, orthogonal, relevant in vitro and in vivo
systems. The ultimate overall goal of this fundamentally translational project is to begin clinical evaluation
of at least one agent based on the novel targets and strategies identified through our work in patients with
this often lethal sarcoma within five years.

Public health relevance
NARRATIVE Synovial sarcoma, an aggressive cancer that primarily affects children and young adults, is characterized by an abnormal protein called SS18-SSX. We hypothesize that SS18-SSX makes synovial sarcomas dependent on specific genes, creating an Achilles' heel that could be targeted by specific inhibitors of the function of those genes. We propose to systematically screen synovial sarcoma cells for such dependencies among genes that often function in cancer and genes likely to be related to the function of SS18-SSX, with the goal of identifying novel targets or existing drugs that can be clinically evaluated in these patients.